A Novel Role of DRA in IBD Pathogenesis

Project Summary/Abstract
Inflammatory Bowel Disease (IBD) is a global health burden currently affecting around 3 million people in the
United States with increasing incidence worldwide. According to a recent report, prevalence of IBD among
US veterans rapidly increased during the past decade. Despite all the advancement, pathogenesis of IBD
is still unclear due to the multifactorial nature of the disease and the treatment options are not adequate.
Therefore, understanding the molecular pathophysiology of IBD is critical for developing effective therapeutic
modalities. Several different mechanisms likely account for the IBD pathogenesis. In this regard, compromised
Intestinal barrier is one of the most critical early event linked to the onset of intestinal inflammation in IBD.
Recent studies have implicated novel roles of epithelial ion transporters (e.g. NHE3 and CFTR) in maintaining
barrier integrity. In this regard, DRA (Down Regulated in Adenoma or SLC26A3) is the key transporter
mediating chloride absorption in the mammalian intestine. DRA KO mice exhibit lack of an adherent inner
mucus layer, altered proliferative homeostasis of the colonic crypts, and are more susceptible to experimental
colitis. The important role of DRA in inflammation is further evident from GWAS, identifying DRA as a novel
IBD susceptibility gene. Further, DRA levels are severely depleted in human IBD patient colonic mucosa and in
mouse models recapitulating IBD. However, the mechanisms underlying this increased susceptibility to
inflammation in response to loss of DRA are not known and warrant detailed investigations. Our
preliminary data provide strong evidence for a novel role of DRA in maintenance of epithelial integrity. Our
preliminary data suggest that loss of DRA may play a key role in breaching the epithelial barrier via multiple
mechanisms e.g. either by directly affecting the TJ/AJ and/or via indirect (related to its Cl-/HCO3- exchange
function, its cytoskeletal interactions and/or microbial dysbiosis). In addition, targeting DRA via its upregulation
appears to be a novel therapeutic approach to restore barrier function and alleviating inflammation. However,
the therapeutic feasibility of targeting DRA to restore barrier function in preclinical models has never been
investigated. Therefore, we hypothesize that i) DRA loss perturbs intestinal barrier function by reducing TJ and
AJ protein expression via posttranscriptional mechanisms involving RNA binding proteins and/or via direct
interactions with cytoskeletal elements. ii) Upregulation of DRA function and expression can alleviate
inflammation via restoration of intestinal barrier function. Our hypothesis will be tested utilizing state-of-the-art
approaches and human/mouse colonoids, Caco-2 cells and KO or transgenic mouse models. Two Specific
Aims have been proposed: Aim 1. Elucidate the post-transcriptional mechanisms modulating gut barrier
function and TJ/AJ proteins in response to DRA deficiency; and Aim 2. Elucidate the novel role of DRA
upregulation in maintenance of intestinal epithelial integrity and tight junction proteins in experimental
models of colitis and colonoids derived from healthy and IBD patients. Successful outcome of these
studies should yield critical insights into the molecular mechanisms of intestinal TJ/AJ regulation and establish
DRA as a novel therapeutic target to manage IBD. Additionally, these studies will provide the applicant a great
training vehicle for becoming an expert in mechanisms underlying the novel role of a membrane chloride
transporter in intestinal tight junction dysregulation and pathogenesis of IBD, as well as train him in cutting-
edge approaches utilizing enteroids, colonoids and advanced imaging techniques to evolve him into an
independent VA investigator focused on IBD research.

Public health relevance
Inflammatory Bowel Disease (IBD) is a common chronic disorder affecting both the general population and our Veterans. There is a dire need to better understand how the disease is developed to improve current treatment options. Leaky gut barrier is a common feature of IBD. Our new findings showed that loss of a protein needed for intestinal chloride absorption, DRA, leads to a leaky gut barrier. The proposed research will examine mechanism by which DRA deficiency in IBD causes leaky barrier and whether increasing DRA expression by beneficial bioactive dietary lipid (LPA) can restore barrier function and prevent inflammation. This is well aligned with the VA mission to improve the heath care of our veterans.